Mtb and HIV/SIV antigen peptide signatures as blood biomarkers to detect early infection to active disease in young children and NHP

ABSTRACT
One million children develop TB annually; but current TB diagnostics exhibit poor performance in children,
and the vast majority (96%) of the 205,000 children who die of TB-related causes each year do not receive
treatment. Such children often present with non-specific symptoms and paucibacillary TB – particularly those
co-infected with HIV – and are not diagnosed, and may then progress to disseminated or extrapulmonary TB
cases that can rapidly progress in the absence of appropriate treatment. In young children, difficulty obtaining
sputum samples used by most front-line TB diagnostics reduces the ability to accurately diagnose TB and
monitor its response to treatment. Thus, non-sputum-based diagnostics are urgently needed to address this
problem, but current versions of such assays either demonstrate poor sensitivity for active TB or cannot
differentiate active disease from latent TB infection or accurately monitor treatment responses.
We have reported that detection of virulence factors secreted by Mycobacterial tuberculosis (Mtb) in serum
can diagnose all forms of TB in children (pulmonary and extrapulmonary TB), including paucibacillary and HIV-
associated TB cases. We have recently shown that multiplex detection of HIV- and Mtb-derived protiens in serum
can sensitively diagnose HIV and TB in young children, and simultaneously monitor their response to HIV and
TB treatment. This is a critical issue for those at highest risk for mortality; very young children who may be
exposed and/or infected with both pathogens while breastfeeding, during the first two years of life. Based on our
success in identifying pathogen-specific peptide biomarkers and developing corresponding diagnostic assays,
we propose to develop a multiplex HIV and TB assay for improved detection and monitoring of HIV viral load
and all stages of TB, from early infection to active TB disease, in young children suspected HIV and TB infections
or HIV/TB co-infections. We propose to achieve this goal through the pursuit of three interlinked specific aims
where we will: 1) establish an assay for multiplex quantification of serum levels of TB-derived factors associated
with each stage of TB development, from early infection to active TB disease in an infant non-human primate TB
model that closely recapitulates the pathology of HIV and TB infection and co-infection; 2) develop a predictive
model based on correlations between TB stage markers, immune responses and TB pathology in this disease
model; and 3) conduct a multi-center validation of this multiplex assay to diagnose HIV infection and latent TB
infections and early and active TB disease in HIV-exposed pediatric cohorts with carefully annotated clinical,
radiological and bacteriological data. Employing a non-human primate model of HIV/TB co-infection and
quantitative proteomics will allow us to identify TB-associated changes corresponding to symptom development
and immune changes associated with disease progression that could not feasibly be detected using human
cohorts. The comprehensive evaluation of our assay in multiple well-characterized pediatric cohorts will facillitate
the rapid translation of these biomarkers into practice and the development of our portable device-based assay.

Public health relevance
NARRATIVE An estimated 205,000 children die of TB-related causes each year, the vast majority of whom do not receive treatment due to missed opportunities to diagnose and successfully treat, as current tests do not sensitively detect all forms of pediatric TB disease. We have reported that our novel serum-based TB assay (developed with the support of our previous R01 funding) can detect all forms of pediatric TB with high sensitivity and specificity, and now propose to extend our assay approach to generate a multiplex assay that can also identify individuals progressing from latent TB to active TB disease, as well as rapidly evaluate a patient’s response to TB therapy to determine treatment efficacy. To do so, we will continue identifying new biomarkers secreted by TB bacilli that identify each stage of TB in a well-established non-human primate model of HIV and TB, and determine the best biomarker combinations and thresholds to distinguish these stages their response to anti-TB treatment, and subsequently evaluate the performance of a multiplex assay develop from these parameters in multi-center cohorts of young children with or without HIV, latent TB infection or active TB.